CSHL Conference on Mouse Molecular Genetics: Development & Disease

[unreadable] DESCRIPTION (provided by applicant): The mouse is undoubtedly the premiere genetic system for a variety of mammalian studies. Significant advances have been made in a number of diverse fields using the mouse as a model system, in particular, in developmental biology, immunology, hematology, neurobiology, and oncology. Over the last two decades, there has been a dramatic increase in experimental studies in the mouse, largely as a result of striking technical and conceptual developments, culminating in the 2007 Nobel prize in physiology or medicine being awarded to three mouse geneticists "for their discoveries of principles for introducing specific gene modifications in mice by the use of embryonic stem cells". This conference application seeks support for the twenty-first of an annual series of meetings that has emerged as the premiere meeting for this field. The meeting series alternates between Cold Spring Harbor and a European venue, with the 2008 meeting to be held at the Cold Spring Harbor Laboratory. The proposed meeting on "Mouse Genetics & Genomics: Development & Disease" will assemble leaders in the field, junior faculty, postdoctoral fellows, and graduate students to discuss the latest research and to share information about new cutting-edge developments in the field. Topics to be discussed for the 2008 meeting will include Disease Models; Neurobiology; Germ Cells and Stem Cells; Epigenetics; Patterning; Organogenesis; Genetics; and Genomics. Given the diverse approaches currently employed in this field, communication among workers is essential to advance research and understanding of fundamental processes in mammalian development, and how these processes are disrupted in a variety of diseases. Oral presentations will be selected by the session chairs in consultation with the organizers. Each session will be chaired by two leading scientists in the field. Selected speakers will include graduate students, postdoctoral fellows, and junior faculty. The meeting will commence with a special lecture in honor of the late Rosa Beddington. There will also be two or three poster sessions where a majority of participants can present their work. The meeting will be of moderate size, and we expect 300-350 mouse geneticists and genomicists are expected in attendance. [unreadable] [unreadable] [unreadable]